Scientific Resource Core

Title: Shared Resource Core
Summary/abstract
Myotonic dystrophy (DM) and facioscapulohumeral muscular dystrophy (FSHD) have multisystem
complications that are serious, progressive, and often disabling. A better understanding of the novel
mechanisms of DM and FSHD has led to identifying several good therapeutic targets. Advances have occurred
more quickly than expected with several experimental drugs in development or clinical trials. There is now
renewed urgency to enhance the translational resources needed to facilitate current and future studies and
clinical trials. To achieve this goal, several aims of the shared resource core propose to sustain and enhance the
resources of the oldest and most comprehensive Registry for patients with myotonic dystrophy type 1 (DM1),
type 2 (DM2), and FSHD. The National Registry for DM and FSHD Patients and Family Members has
facilitated research for 23 years with the same overarching goals to assist researchers in the recruitment of
patients for clinical studies and trials, to develop an extensive database of longitudinal patient information, and
to promote community outreach with patients, family members, clinicians, and researchers. Core Registry
methods include patient-reported questionnaires and curated medical records, annual surveys to track disease
progression, and researchers applying to access data or for assistance with recruitment. Overall, the Registry
has functioned effectively, but several changes are needed to make it more effective in the future. First, the core
activity and methods of the National Registry described above will be sustained to help maintain two-way
communication between researchers and patients and to help advance research on muscular dystrophy. A
second aim is to expand the Registry dataset and prepare for targeted recruitment based on clinical and genetic
characteristics in DM1. Highlights of this aim include incorporating remote genetic and clinical
characterization of Registry members with DM1, including quantified assessments of strength, function, and
myotonia. A third aim is to expand & diversify Registry engagement and prepare for comparative studies of
long-term drug effects. Specific tasks include recruiting patients from neuromuscular clinics not typically near
DM and FSHD research centers, translating forms to Spanish, and expanding online presence and enrollment.
A fourth goal is to promote research on understudied manifestations of DM and FSHD, which have important
implications for quality of life. This goal builds upon current data in the Registry on several topics important to
patients, such as gastrointestinal manifestations in DM, vision problems in FSHD, and neoplasms in DM. A key
proposal here is to add data to the Registry on women’s health in DM and FSHD and expand data collection on
smooth muscle involvement in DM and gastrointestinal and genitourinary assessments in FSHD. Overall, the
Shared Resource Core will serve the needs of researchers in our Center, the larger community of investigators
who study autosomal dominant forms of muscular dystrophy, and the patients and families living with these
disorders.